Experience-dependent plasticity and dynamics in vitro

DESCRIPTION (provided by applicant): Cortical computations are the result of neural dynamics: the spatial-temporal patterns created by the flow of activity through cortical networks. It is from neural dynamics that the computations that underlie cognition emerge. Additionally, it is ultimately not the effect genes or cells in isolation that underlie cognitive abnormalities, such as those observed in neurofibromatosis or autism, but how they alter function at the network level. Over the past decades significant progress has been made regarding the learning rules governing synaptic strength, as well as in the description of experience-dependent changes in cortical processing using in vivo and imaging approaches. However, less progress has been made in bridging these levels of analyses;there is an explanatory gap in the ability of synaptic and cellular properties to account for the emergent properties of neural networks. Indeed, the mechanisms by which the properties of millions of synapses and thousands of neurons are adjusted to produce, not only a controlled (as opposed to epileptic) flow of activity, but a computation as a result of neural dynamics are not understood. The goal in the current proposal is to use cortical networks in vitro as a 'reduced preparation'to study the fundamental principals underlying neural processing and dynamics within local cortical networks. Cortical neurons develop selective responses to stimuli in an experience-dependent manner. This selectivity plays a fundamental role in sensory processing and pattern recognition, and appears to develop independently of whether the stimuli are auditory, somatosensory or visual in nature. The learning rules responsible for the emergence of selectivity are presumably not coherently engaged in traditional in vitro preparations, since these normally 'develop'in the absence of any input structure, much like the visual or auditory system being deprived of patterned input. We will chronically expose cortical networks in vitro to simple input patterns to address a number of fundamental issues, including: 1) whether neurons in vitro can develop stimulus-selective responses in an 'experience-dependent'fashion, and 2) to elucidate the computational role of spontaneous network dynamics. By advancing our understanding of how sensory-experience shapes network function and dynamics, this research will contribute to the elucidation of both normal and pathological cortical function. Furthermore the development of an in vitro model of cortical function will prove valuable to the development of experimental models for diseases affecting cortical function, such as neurofibromatosis and Alzheimer's disease.